Mechanisms governing development of large-scale networks in visual cortex

Project Summary/Abstract
Sensory perception requires the coordinated activity of tens of thousands of neurons functioning together in
large-scale networks. The capabilities of these networks are defined and constrained by their development, yet
the mechanisms underlying their formation remain incompletely understood. In the visual cortex of primates and
carnivores, modular networks consisting of nearby neurons sharing coordinated activity and similar tuning
properties extend across millimeters of cortical surface. Prior to eye-opening, such large-scale networks are
already evident in correlated spontaneous activity, whose structure can predict future visually-evoked responses.
We have previously shown that local recurrent mechanisms utilizing local excitation / lateral inhibition (LELI)
interactions account for these modular functional networks in the week prior to eye-opening. However, major
gaps remain in our ability to relate early network structure to mature sensory function. All previous work occurred
at ages when spontaneous activity is already modular, meaning that its developmental origins remain unclear.
Furthermore, early modular networks undergo refinement prior to eye-opening, but the role of changes in
recurrent interactions versus changes in inputs is unknown. The experiments in this proposal will address these
gaps, first by imaging spontaneous activity earlier in development than prior work, beginning at an age when
cortical neurons are still completing their migration. This will allow us to capture the onset of modular activity in
the cortex and investigate whether the same mechanisms that underlie modular activity later in development are
also involved from the earliest stages. In order to determine if intracortical circuits are responsible for generating
dominant modes of activity that refine in the week prior to eye-opening and serve as a dynamic scaffold for future
visual representations, we will utilize our ability to directly stimulate the cortex with spatially-patterned
optogenetics. These experiments will allow us to separate the contributions of changes in input from those of
changes within recurrent circuits to both the developmental refinement of cortical networks and their potential
role as a template for the future structure of visually-evoked representations. Finally, in order to understand
whether a modular organization generated through recurrent LELI mechanisms exists elsewhere in visual
cortices, we will image spontaneous activity in higher visual areas throughout development, and use patterned
optogenetic stimulation to directly test the role of LELI mechanisms outside V1. Understanding the mechanisms
through which modular network structure first emerges and whether recurrent circuits serve to generate dominant
modes of activity that function as templates for sensory representations is critical for understanding how
functional visual circuits are constructed during development. Determining if such mechanisms operate
throughout higher visual areas is key for understanding the function organization of these regions. Collectively,
the studies in this proposal will provide critical new insights into both the developmental origins of millimeter-
scale functional networks and their role in shaping future functional organization throughout the visual cortex.

Public health relevance
Project Narrative This proposal will identify the developmental origins of large-scale networks in the visual cortex and determine how this early functional organization shapes the mature networks that underlie later sensory perception. These insights will be relevant for understanding how early life perturbations contribute to disease pathology in neurodevelopmental disorders that exhibit abnormal sensory processing, such as autism and schizophrenia. Ultimately, understanding the mechanisms of early network development may provide avenues for potential therapeutic interventions in these diseases.